Providence 650 Summer Research Program

As diversity among Veterans increases, it is important that the VA workforce reflects the diversity of those we
serve. Veterans benefit from diversity in the VA scientific research enterprise because the complex
biopsychosocial issues Veterans face need multi-faceted and creative responses. A scientific workforce from
diverse backgrounds and life experiences brings novel insights critical for improving healthcare and the lives of
Veterans. However, access to educational and research opportunities necessary to obtain advanced degrees
remains out of reach for many, particularly those from historically underrepresented groups, Veterans, and
individuals living with disabilities. To address these challenges, we leveraged the support from the VA Office of
Research and Development Summer Research Program Pilot funding to develop a robust Summer
Undergraduate Research Fellowship (SURF) training program housed in the Providence VA Center for
Innovation in Long-Term Services and Supports (LTSS-COIN).
Training in the LTSS-COIN is guided by the Zone of Proximal Development (ZPD) theory, which focuses on
providing individualized support for learners through mentorship, interactions to allow learners to
observe/practice skills, and activities (or “scaffolding”) to increase competence in the identified learning
outcome (e.g., knowledge, skills, awareness, practices, and cultural/social savvy). Guided by the ZPD theory,
the SURF program has three primary components: 1) individualized mentoring based on a needs assessment
and a co-created individual development plan, 2) formal and informal instruction activities, and 3) completion of
a VA summer research project culminating in a poster presentation.
The Providence Summer Undergraduate Research Fellowship (SURF) is a collaborative effort between the
Center for Innovation in Long-Term Services and Supports (LTSS-COIN) and The Leadership Alliance at
Brown University to provide a 9-week program of mentorship, research, formal instruction, and experiential
learning. The goal of the SURF program is to increase the interest and readiness of underrepresented students
to build careers in the health services, behavioral, clinical, health services, rehabilitative, and biomedical
workforce in VA. To achieve this goal, we propose the following objectives: 1) Provide a curriculum of didactic
and mentored experiential learning experiences focused on research, stakeholder engagement, leadership
skills, and professional development; 2) Educate students on structure, mission, and value of VA and VA
research; and 3) Improve confidence in academic abilities and potential to encourage students to pursue an
advanced degree in a field related to healthcare research.
Since 2022, SURF has been part of the VA Summer Research Program Pilot. We have successfully built our
partnership with Brown University, implemented our curriculum, conducted student evaluations, and work to
continually improve the program based on feedback. Over the past two summers, we hosted 6 students and
have plans to host 6 in Summer 2024. Our students have provided positive feedback on the program and have
demonstrated excellent short-term outcomes, including acceptance into prestigious graduate and medical
schools. Furthermore, several students have continued to work with their mentors on VA research and
manuscripts. With this application, we plan to continue growing the SURF program and creating new learning
opportunities for our students.

Public health relevance
Veterans receive better care if the VA workforce reflects the diversity of the people we serve. Research teams from diverse backgrounds and life experiences are important for finding creative ideas to improve healthcare and the lives of Veterans. However, access to education and research training is out of reach for many people, including those from underrepresented groups, Veterans, and persons with disabilities. The goal of the Summer Undergraduate Research Fellowship (SURF) program at Providence VA is to increase the interest and readiness of underrepresented students to build careers in research. SURF provides students with a 9- week program of mentorship, research activities, formal training, and learning experiences. Students participate in creating and individualized mentoring plan, formal and informal instruction, and present a poster from their research experience. SURF was part of the VA Summer Research Program pilot study and over the past two years, we have successfully hosted 6 students with plans to double that number in Summer 2024.